Administrative Core

ADMINISTRATIVE CORE - ABSTRACT
The Center for Environmental Exposures and Disease (CEED) aims to address the environmental healthrelated
concerns of New Jersey (NJ) residents by engaging community members, organizations, and agencies
as advisors and research partners. CEED provides critical investment and infrastructure for multidisciplinary,
collaborative research and organizes training the next generation of environmental health scientists. The
primary goal of the Administrative Core is to implement the strategic vision of CEED, coordinate and manage
Center activities, and integrate and synthesize input from components to ensure that the Center’s mission of
improving environmental health is achieved. Specifically, the Core coordinates and supports research, data
management and sharing, recruitment and training, community engagement, infrastructure, and mentoring.
Providing operational and fiduciary oversight, the Administrative Core will allocate resources from the grant
and matching funds from the University to facilitate cutting-edge basic research, community-engaged
participatory research, and training in environmental health sciences. Working closely with the Community
Engagement Core (CEC), the Administrative Core will ensure the translation and dissemination of research
findings to communities and valued partners. The Administrative Core will also ensure that CEED’s prevention
and intervention strategies are assessed for efficacy and implemented to address the environmental health
concerns of NJ communities. During the current funding period, the Administrative Core made notable
progress in recruiting members across departments and schools within Rutgers and three other NJ universities
and capitalized on substantial institutional support to improve research capabilities. Leaders of CEED are
recognized across the university and the scientific community for their outstanding mentorship and research.
Collectively, these accomplishments provide a significant platform to launch and advance research and training
initiatives in the next grant cycle. Our specific aims are to: (1) Create and foster a structured, interdisciplinary
environment that facilitates impactful, collaborative research that can be translated to improve health in NJ and
nationwide; (2) Engage and amplify multidisciplinary perspectives in environmental health research and
translation; and (3) Provide support for the training and career development of the next generation of
environmental health scientists.